Clonal lineage tracing of HIV specific NK memory cells

ABSTRACT
Immune memory is a critical aspect of adaptive immunity. The presence of antigen-specific memory cells can
provide immune control against infection, and for this reason, immunological memory is a cornerstone of vaccine
protection. Adaptive immunity has long been thought to be the sole domain of B and T cells, but exciting new
studies of natural killer (NK) cells memory responses has challenged this paradigm. In the case of HIV, there is
evidence from animal models that rare NK cells can mount long-lasting memory responses to HIV antigens, but
there is limited data that define HIV-specific NK memory in humans. NK memory has been most clearly
demonstrated for HCMV, where recent studies have demonstrated the persistence of NK cell clones using a
novel method for cell lineage tracking called ASAP-seq. ASAP-seq uses mitochondrial DNA mutations as
endogenous barcodes for long-lived NK cell clonotypes, much like receptor rearrangements are used to mark B
and T cell lineages. In addition, this method captures protein expression that can be used to identify markers
associated with long-lived NK cell clones. ASAP-seq also captures epigenetic data that provides insights into
the cellular changes that are associated with the NK memory cells of interest. Here we propose to apply this
method to samples from a unique 30-year cohort of HIV infected women, where there are banked longitudinal
samples starting prior to HIV-infection. Thus, we will examine NK cell populations before and after HIV infection,
which will enable detection of new NK memory cell clones that arise/expand after HIV acquisition. In addition,
we will perform ASAP-seq on HIV+ cases with and without HCMV co-infection to control for the potential
confounding effect of NK memory responses to HCMV. Together, these complementary approaches are
designed to identify NK memory cell clones that are specific to HIV. If HIV-specific NK memory is discovered
through this innovative work, it will lay the foundation for many future studies, ranging from basic studies to define
epitope specificity, and HIV-specific NK cell phenotype and function to more applied work to harness these
responses to prevent and cure HIV infections.

Public health relevance
PROJECT NARRATIVE Eliciting protective immunity to HIV is critical to vaccine efficacy and natural killer (NK) memory cells could be harnessed for this purpose. Here we propose to determine if there is an NK memory cell response to HIV in humans. This work will lay the foundation for pursuing NK memory as an aspect of HIV prevention.